Administrative Supplement request for GM117155

PROJECT SUMMARY
The establishment of bipolar spindles during meiotic divisions ensures accurate chromosome segregation.
Characterization of microtubule organizing center (MTOC) dynamics will help understand the causes of gamete
aneuploidy. The processes required for the formation of bipolar MTOCs are sexually dimorphic. Chromosome
segregation during spermatogenesis is mediated by MTOCs containing centrioles that duplicate once prior to
meiosis I and again prior to meiosis II. In contrast, oocytes form multiple acentriolar MTOC fragments that
coalesce together to form bipolar spindles.
We have developed new research tools and adapted novel techniques to define and compare MTOC
processes between mammalian spermatogenesis and oogenesis. In Aim 1, we will assess meiotic progression
in the absence of key microtubule organizing center (MTOC) regulators. In Aim 2, we aim to discover and
characterize novel components of MTOCs during oogenesis and spermatogenesis. In order to achieve our
objectives, we have developed a method to increase the magnification of spermatocytes and oocytes by
combining cryosectioning with tissue expansion and super-resolution microscopy to enable us to view fine
structural features of MTOCs. In addition, with donated, deidentified human gonad samples that we receive via
approved protocols with organ procurement organizations, we are performing short-term culture experiments
and chemical modulation using specific small molecule inhibitors against cell cycle kinases.
Our aims can only be addressed with the appropriate equipment. Unfortunately, our cryostat recently broke
down without an option for repair (discontinued model). Therefore, we are requesting a new, improved cryostat
system to alleviate this issue. The Epredia Cryostar NX70 we propose to obtain with equipment supplement
funding is optimal for our needs, a superior product, and will solve our current cryosectioning issue.
By defining the novel processes required for centrosome and acentriolar MTOC biogenesis during mammalian
meiosis we will develop new concepts of how meiotic chromosome dynamics and segregation are regulated.
Our proposed research will contribute to diagnosing causes of gamete aneuploidy and help with efforts to reduce
these events that cause birth defects, affect physical and mental development, and increase the risk of infertility.

Public health relevance
NARRATIVE: During the formation of sperm and eggs, chromosomes must segregate accurately. However, approximately 10% of clinically reported pregnancies are chromosomally abnormal, resulting in pregnancy loss or genetic defects such as Down syndrome. Very little is known about the genetic failures that cause these chromosomal abnormalities in gametes; however, we will significantly enhance our knowledge of this phenomenon by achieving the goals set within this administrative supplement (PA-20-272).